Neural mechanisms of psilocybin action in the frontal cortex

PROJECT SUMMARY
Serotonergic psychedelics are best known for altering perception, cognition, and mood. Recently, there has been
a resurgence in clinical trials investigating psychedelics for their potential in treating neuropsychiatric illnesses,
such as substance use disorder. Psilocybin-assisted therapy, for example, holds promise in treating alcohol,
opioid, or stimulant addiction. It has received attention for showing positive, long-lasting effects after only a single
treatment. Still, it is unknown how psilocybin acts on the brain immediately after administration to begin altering
neuronal processing. This proposal aims to determine psilocybin’s cellular and microcircuit mechanisms of action
in the mouse medial frontal cortex, with a specific focus on GABAergic interneurons and soma-dendrite coupling.
Interneurons in the frontal cortex express serotonin receptors and likely respond to psilocybin to mediate
changes in cortical information processing. Meanwhile, soma-dendrite coupling controls the efficiency of
information flow in pyramidal neurons, thereby governing spike output, and it is associated with cognitive
processing. In the medial frontal cortex, psilocybin-driven changes in microcircuit activity and soma-dendrite
coupling may therefore underlie the cognitive state that accompanies a psychedelic experience. More
importantly, these cellular and microcircuit-level changes may be linked to psilocybin’s therapeutic effects. In
Aim 1 of this proposal, we will use two-photon calcium imaging to determine how psilocybin influences the activity
of three dendrite-modulating interneuron populations in the medial frontal cortex. Additionally, we will examine
whether the observed activity changes are mediated by specific serotonin receptors expressed in these
interneuron populations. In Aim 2, we will use multi-plane calcium imaging to determine how psilocybin influences
soma-dendrite coupling in pyramidal neurons of the medial frontal cortex. We will also perturb the activity of the
three dendrite-modulating interneuron populations to determine their role in shaping soma-dendrite coupling
during psilocybin action. The proposed experiments are designed to elucidate how psilocybin shapes cortical
computations. In doing so, this proposal will advance our understanding of the neurobiology of psychedelics,
specifically in the circuits that are important for executive function and impulse control, which will lead to improved
treatments for addiction.

Public health relevance
PROJECT NARRATIVE Classic psychedelics, such as psilocybin, are being investigated as a potential treatment for substance use disorder. This project examines how psilocybin influences neuronal activity and single-neuron computations in the neocortex. This proposal will advance our understanding of the neurobiology of psilocybin action and will provide mechanistic insight to improve psilocybin-assisted therapy for addiction.